Administrative Core

There is extensive evidence of persistent and in some areas worsening disparities in healthcare delivery,
quality, and outcomes experienced by minority groups in the U.S. Despite multiple calls to action, the
reorienting and restructuring of health systems to rapidly implement and test solutions to address health
disparities have yet to be realized. Toward this goal, the Administrative Core (AC) of our Columbia-Cornell-
Einstein EQUIP+ Center for Learning Health System (LHS) Science will be tasked with building and
overseeing the infrastructure that supports LHS Scientists to develop and conduct innovative PCOR/CER
projects at the intersection of health equity and quality. With Columbia University serving as the academic and
administrative hub, the EQUIP+ Center brings together three world-class academic institutions in New York
City: Columbia University, Weill Cornell Medicine, and Albert Einstein College of Medicine, and their large,
affiliated healthcare delivery systems serving diverse patient populations. To build a robust LHS infrastructure,
the AC will leverage the vast complementary training and research assets of Columbia and its partners. Under
the AC’s leadership, the EQUIP+ Center will enhance existing resources and develop new structures to train
and support LHS Scientists, including tailored didactics and mentorship, PCOR/CER methodology and
implementation science consults, and data science, statistics, and informatics tools and services, within and
across partner institutions. With strong, centralized leadership, the AC will coordinate and communicate
effectively with all interrelated Cores of the EQUIP+ Center to achieve their specific aims. Importantly, the AC
will ensure that the individual training and research needs of a diverse group of LHS Scientists are met. The
AC will also engage key stakeholders, representing patients, community, healthcare providers, and institutional
leaders at every stage of the LHS project cycle. To accomplish these strategic activities, the AC will pursue the
following specific aims: Aim 1–Serve as a centralized hub to provide leadership, oversight, coordination, and
communication of all proposed activities of the EQUIP+ Center and across its Cores; Aim 2–Create and
coordinate opportunities for effective and meaningful engagement of participants and community and
stakeholder partners; Aim 3–Recruit LHS Scientists from across our LHS partners and leverage collaborative
relationships to provide training, mentoring, and research opportunities across institutions; and Aim 4–Conduct
a rigorous comprehensive program evaluation to continuously improve and demonstrate the value of
embedded LHS Scientist training and research. The AC will leverage the EQUIP+ Center’s network of
resources to advance the field of LHS Science and develop the next generation of LHS Scientists to improve
health equity, quality, and safety.